MEDIATOR RELEASE IN ALLERGIC AND ASPIRIN-INDUCED RHINITIS

To characterize the time course of symptoms and mediator release during the early and late phase of nasal allergic reactions and compare this with that of aspirin-induced rhinorrhea.